Molecular basis of the differential expression of the VieSAB regulatory system n Vibrio cholerae biotypes

? DESCRIPTION (provided by applicant: Cholera is a waterborne diarrheal disease caused by Vibrio cholerae of serogroup O1 and O139. The serogroup O1 can be divided in two biotypes: classical and El Tor. The current and seventh cholera pandemic is characterized by the predominance of the El Tor biotype. Recently, hybrid V. cholerae O1 clinical isolates (the Hybrid O1 and the El Tor variant) with attributes of both biotypes and enhanced virulence have been identified. Lateral gene transfer, transcriptional silencing of xenogenic DNA and gain of function through anti-silencing could play an important role in biotype evolution. The histone-like nucleoid structuring protein (H-NS) is a global regulator known to silence the transcription of laterally- acquired genes. We have shown that H-NS and quorum sensing differentially regulates the transcription of the vieSAB operon encoding a three-component regulatory system in V. cholerae biotypes. The VieSAB regulatory system is expressed in classical biotype V. cholerae where it regulates the expression of 10 % of the genome. Genes regulated by this system include those required to make cholera toxin and biofilm development. Thus, the VieSAB regulatory system is a major contributor to biotype-specific phenotypic differences impacting V. cholerae pathogenesis, environmental fitness and transmission. We found that H-NS binds with similar affinity to the promoter of classical and El Tor biotype vieSAB. However, H-NS was found to function as weaker repressor of vieSAB in the classical biotype. In this application we propose to characterize the regulation of vieSAB transcription and establish the basis for its differential expression in V. cholerae biotypes. In aim 1, we will determine the molecular basis for the differential transcriptional silencing of vieSAB by H-NS in classical and El Tor biotype V. cholerae. In aim 2, we will determine the connection between quorum sensing and vieSAB transcription in the El Tor biotype. Our study will likely identify new regulators that modulate V. cholerae pathogenesis by acting through the VieSAB regulatory system. Further, a better understanding of the molecular determinants of biotype-specific behavior could support the development of more effective cholera management strategies and perhaps even predict the emergence of new pathogenic variants.

Public health relevance
PUBLIC HEALTH RELEVANCE: The diarrheal disease cholera is caused by Vibrio cholerae serogroup O1 of classical and El Tor biotypes and to a less degree, serogroup O139. The severity of recent outbreaks and the emergence of new variants with attributes of both biotypes is a major public health concern. In this study we examine the basis for the differential expression in V. cholerae biotypes of a regulatory system (VieSAB) controlling bacterial virulence, environmental fitness and disease transmission.